Clinical Pharmacology Training Program

PROJECT SUMMARY/ABSTRACT
This is a proposal to continue the support of two pediatric and maternal-fetal clinical pharmacology slots in a
long standing collaborative postdoctoral training program in at Children’s Hospital of Philadelphia (CHOP) and
Thomas Jefferson University (TJU). These slots have been supported by NICHD for the past 2 cycles under a
parent NIGMS T32 grant. Changes to the approach of NICHD to support clinical pharmacology slots prompted
this application. The mission of our joint program is to train the next generation of drug development scientists
to ensure innovation in therapeutics that transforms disease management. To accomplish this, we seek to
identify diverse basic, translational, and clinical investigators and provide a curriculum that prepares trainees for
research careers in academia, industry, or regulatory agencies. The program is designed for postdoctoral
fellows, including MDs, MD-PhDs, PharmDs, and PhDs, leveraging the exceptional research environment of our
two institutions to support training that addresses workforce needs in the field. Our 2-year program pairs a well-
established curriculum of didactic coursework, conferences, and rotations with mentored research in
mechanism-based discovery, drug development, pharmacometrics, experimental medicine, and drug safety; the
majority of fellows’ time is focused on hypothesis-driven research. The breadth of clinical pharmacology is
delivered using a framework built on the TJU Training Program in Human Investigation. Courses cover clinical
pharmacology, clinical trials design, biostatistics, pharmacoepidemiology, pharmacometrics, regulatory science,
research ethics, data management, leadership, grant writing and presentation skills. Advanced training in
academic and industrial pharmacometrics is an elective offering. Conferences include journal club in human
therapeutics, research ethics, and seminars in human therapeutics. Rotations provide experience in review of
human subjects research on an institutional review board (IRBs); clinical trial execution in the TJU Clinical
Research Unit or within the inpatient setting at CHOP; analytic method development to support trainee
pharmacokinetic studies; or the critical analysis of the scientific literature on the editorial board of the Annals of
Internal Medicine. Fellows customize their education by selecting electives congruent with career aspirations,
including off-site rotations at industrial drug development partners and/or regulatory agencies such as the Food
and Drug Administration (FDA). Opportunities in pediatric, maternal, and adult experimental therapeutics are
offered by preceptors representing 6 broad areas of distinction, including cancer biology, cardiopulmonary
medicine, neurosciences, immunology and infectious diseases, neonatology and maternal therapeutics, and
pediatric therapeutics. Preceptors are selected based on their productive research programs related to
therapeutics, training success, and commitment to training. This program will continue to build upon an
exemplary record of recruiting diverse trainees who have been uniformly successful in academia, the
biopharmaceutical industry, and the FDA.

Public health relevance
PROJECT NARRATIVE Clinical pharmacology is a broad discipline focused on improving the effectiveness and safety of drugs in humans. Yet, at this time of scientific opportunity, a critical shortage of trained individuals limits the discovery and development of drugs for use in adults, children, and pregnant women. To fill that gap, the Children’s Hospital of Philadelphia and Thomas Jefferson University and have developed a successful joint Clinical Pharmacology Fellowship Program to train postdoctoral clinician scientists dedicated to translating new discoveries into drugs that revolutionize pediatric and maternal care.